Social media as a social mechanism of non-cigarette tobacco use: Engaging young adults to examine tobacco culture online

PROJECT SUMMARY/ABSTRACT
Adolescents and young adults (AYA) are exposed to, share, and create content about non-cigarette other
tobacco products (OTP) on social media, which has been demonstrated to shape tobacco-related perceptions
and behaviors. New research has documented content that promotes negative health behaviors including OTP
use on TikTok, a social media app on which users create and share short-form videos and that is regularly
used by more than 60% of US teens. However, TikTok content changes quickly, and it is unknown what OTP
message and delivery features are used on TikTok, especially over time, and how they affect message reach
and engagement. The long-term goals of this research program are to elucidate social media’s influence on
AYA OTP use and to inform unique up-to-date regulatory and public health interventions appropriate for
different tobacco products, social media platforms, and generations of young people. The overall objective of
this application is to identify what and how OTP messages (i.e., perceptions, opinions, advice, information) are
conveyed in short-form social media videos created by TikTok users using an adaptive community-engaged
approach. The rationale is that adaptive youth-engaged investigation will illuminate how social media might
perpetuate pro-tobacco sentiments in a way that is transferable to other platforms and risk behaviors over time.
The objective will be addressed with three aims: (1) Identify and characterize underlying messages (e.g.,
perceptions, information) in OTP content on the short-form video-based social media platform TikTok, (2)
Elucidate how delivery features (i.e., app features, creator choices) convey OTP messages on TikTok; (3)
Estimate the relationships between key OTP messages and delivery features and video reach (i.e., views) and
engagement (e.g., likes, comments) on TikTok. These aims will be accomplished in a longitudinal
observational study that identifies OTP TikTok content by training the TikTok algorithm to push relevant
content to TikTok’s For You Page (i.e., “feed”) for multiple accounts. The study leverages both qualitative and
quantitative analytic techniques and engages YA researchers at two sites in all aspects of study design,
execution, and dissemination. The research proposed is innovative, in the applicants’ opinion, because its
immersive, youth-engaged approach can simulate the user experience and provide rich, rigorous,
interpretation of the OTP messages embedded in AYA’s social media environment. The proposed research is
significant because it will help scholars and practitioners contextualize AYA OTP use in the information
environment on TikTok and, by identifying video features that stay popular and engaging over time, it can
enhance the authenticity of health communication that counters pro-tobacco sentiments on TikTok. Ultimately,
such knowledge has the potential to enhance primary prevention efforts that reduce AYA nicotine addiction
and tobacco use.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on identifying shared experiences, opinions, advice, (mis)information, and persistent delivery features of those messages in tobacco product culture on social media, a key socio-ecological feature of the environment of adolescent and young adult (AYA) tobacco use. With this information, there is potential for significant improvement in responsiveness of research and practice to current AYA needs and authenticity of social media interventions for AYA. The project is relevant to NIDA’s mission because it will advance science on the social ecological environment and social mechanisms of nicotine addiction among adolescents and young adults.